METHODS DEVELOPMENT FOR PHYTOCHEMICAL COMPLIANCE MARKERS

The objective of this Master Agreement Order is to obtain analytical chemical analysis of phytochemical compliance markers in experimental foods and in biological fluids of humans consuming these foods.